A Targeted Combination Therapy Approach for AML

PROJECT SUMMARY/ ABSTRACT Treatment of acute myeloid leukemia (AML) has improved but five-year survival rates are still <60% for adult and pediatric patients. Current therapies are very toxic, can cause long-term side effects, and are often contraindicated for elderly patients. Our goal is to develop a molecularly-targeted therapy for AML with better efficacy and reduced toxicity. MERTK tyrosine kinase is ectopically expressed in >90% of pediatric and adult AML patient samples. MRX-2843 is a novel small molecule that inhibits MERTK and FLT3, a known therapeutic target in AML. MRX-2843 has robust activity in preclinical models and is currently in phase I clinical trials; however, the utility of molecularly-targeted monotherapies has been limited by development of resistance. Thus, we sought to identify signaling pathways that synergize with MRX-2843 to inhibit leukemia cell expansion. Using a kinase inhibitor library screen, we found synergistic interactions between MRX-2843 and RKI-1447, an inhibitor of rho-associated protein kinases (ROCK1 and ROCK2). ROCK1 down-regulation reduces leukocyte affinity for chemokines in the protective bone marrow niche and ROCK inhibition reduces expansion of AML blasts in patient sample cultures, induces AML cell death, and prolongs survival in murine AML models. MRX-2843/RKI-1447 combination therapy synergistically reduced AML cell expansion in vitro and these effects correlated with changes in cell cycle progression and induction of apoptosis. Preliminary data also suggest that ROCK1/2 inhibition can promote AML sensitivity to MRX-2843 in the bone marrow. We hypothesize that simultaneous inhibition of ROCK1/2 and MERTK/FLT3 will decrease disease burden and prolong survival, both alone and in combination with standard AML induction chemotherapy, in murine AML models. To test this idea, the impact of treatment with MRX-2843, GSK269962A, and/or chemotherapy will be determined in mice with human AML cell line and/or patient derived xenografts. To identify the targets important for therapeutic synergy, shRNA-expressing cell line derivatives (shMERTK, shROCK1, shROCK2, shCONTROL) will be tested in xenograft models in combination with MRX-2843, GSK269962A, or vehicle. To further evaluate the ability of the combination therapy to target bone marrow disease, the impact of treatment with MRX-2843 and/or GSK269962A will be determined using 3-dimensional biomimicry cultures derived from a panel of AML patient samples, which recapitulate many features of the normal bone marrow niche, including protection from chemotherapy, and provide a robust platform for therapeutic testing. Together these experiments will assess the utility of ROCK1/2 and MERTK/FLT3 inhibitor combination therapies for treatment of AML, provide important information about the efficacy and toxicity of the combination therapy in preclinical mouse models, and may lead to development of a powerful approach to treat AML more effectively and with less toxicity by 1) disrupting the protective interactions between bone marrow stromal cells and leukemic blasts and 2) inhibiting specific molecular targets to induce leukemia cell death.

Public health relevance
PROJECT NARATIVE Treatment of acute myeloid leukemia (AML) has significantly improved but average five-year survival rates are still under 60% for both adult and pediatric patients. In addition, current AML therapies are very toxic, can cause long-term side effects, and are often advised against for elderly patients due to unacceptable morbidity and mortality. The experiments in this proposal evaluate therapeutic effects mediated by a novel combination therapy, in preclinical models, and are essential to support continued development of this targeted therapy, with the long-term goal of improving the outcomes and quality of life for pediatric and adult patients with AML.